Hilton Head Solid State Sensors, Actuators and Microsystems Workshop

Project Summary
The 21st Hilton Head Workshop (HH2024) on Solid-State Sensors, Actuators, and Microsystems is slated for
June 2 - 6, 2024, at Sonesta Resort, Hilton Head Island, SC, commemorating its 40th anniversary. This biennial
event since 1984 celebrates Micro-Electro-Mechanical Systems (MEMS) achievements, envisions future
challenges, and aims to address global and national grand challenges in the next 40 years. HH2024, a premier
MEMS and Microsystems conference, expects 350-500 participants from diverse academic, industry, and
government backgrounds. Past workshops facilitated interactive discussions on microfabrication technologies,
presenting recent advancements for sensing, actuation devices, and microsystems across physical, chemical,
and biomedical applications. Emerging from a global pandemic, HH2022 focused on "Preparation and
Prevention: Tackling our Grand Challenges," exploring heterogeneous microsystems' potential impact on global
healthcare and inspiring collaborations. Highlighting nano- and microtechnologies for biomedical imaging,
diagnostics, drug delivery, implants, and regenerative medicine, HH2024 encourages interdisciplinary
collaboration among various disciplines, including engineering, physics, chemistry, biology, and medicine.
Leveraging support from the NIH, the workshop intends to support underrepresented groups in science and
engineering through travel awards. Overall, HH2024 reflects NIH's mission by advancing technology, exploring
biomedical applications, fostering collaboration, and facilitating research translation for improved human health.

Public health relevance
Project Narrative The 21st in the series of Hilton Head Workshops (HH2024) on the science and technology of Solid-State Sensors, Actuators, and Microsystems will take place June 2 - 6, 2024 at the Sonesta Resort on Hilton Head Island, SC. Here we propose to utilize the support from the NIH as travel awards for student trainees, post- doctoral fellows, and junior faculty from various backgrounds to attend this premier academic workshop and increase the diversity and inclusion of our field.